Mechanisms regulating telomere length, protection and replication

PROJECT SUMMARY
Telomeres are TTAGGG repetitive DNA-protein complexes at chromosome ends required to solve three
significant problems critical for the maintenance of genome stability. The “end replication problem” is due to
the inability of DNA polymerase to completely copy the lagging strand of chromosome ends, necessitating
telomerase to synthesize the 3’ G-strand. The CTC1-STN1-TEN1 complex recruits DNA primase-polymerase
alpha to promote fill-in synthesis of the 5’ C-strand. A major gap in our knowledge is how G- and C-strand
synthesis are coordinated to maintain telomere length. We have previously shown that the POT1 protein
participates in both G- and C-strand synthesis at mouse telomeres. To determine whether human POT1
coordinates telomere length maintenance, we will use state-of-the-art biochemical, structural, cellular and
genetic approaches to explore the possibility that a phosoho de-phopho switch occurs on hPOT1 to coordinate
the recruitment of telomerase and CST to telomeres to maintain telomere length. The telomere “end protection
problem” is due to the fact that telomere ends resemble DNA double-strand breaks, which must be protected
by the shelterin complex to prevent the activation of a DNA damage response. We have previously shown that
shelterin components TRF2-RAP1 represses telomere homology directed repair (HDR). To determine
mechanistically how TRF2-RAP1 protects telomeres from engaging in HDR, we conducted genome-wide
CRISPR screens and IP-mass spectrometry. We identified BLM and ADAR1p110 as potential candidates
proteins involved in telomere HDR. Using purified proteins, we developed a novel telomere D-loop strand
invasion assay and a telomere D-loop unwinding assay to address how BLM participates in telomere HDR. We
also developed a telomere R-loop assay to determine mechanistically how telomere R-loops are resolved by
ADAR1p110. The “end replication problem” stems from the observation that telomeres are difficult to replicate
regions in the genome. To address the gap in knowledge of what novel proteins are involved in telomere
replication, we used BioID to identify Claspin as a TRF2 interacting protein involved in DNA replication. We will
determine mechanistically how Claspin resolves telomere replication stress, using a telomere single-molecule
analysis of replicated DNA to measure the speed of telomere replication fork progression. Using this system, we
will also test whether TRF2 binding proteins identified in our CRISPR screens are required for telomere
replication. We invented an innovative technique called COMET-FISH that combines strand-specific
chromosome-orientation (CO)-FISH with immuno-metaphase-FISH, to visualize C- or G-strand-specific
localization of Claspin to telomeres during replication stress. Our proposed research will yield new mechanistic
insights into how telomeres are protected, maintained and replicated, with broad future implications for
understanding the treatment of human diseases including cancer and aging.

Public health relevance
PROJECT NARRATIVE In this proposal, we will use genomic screens, structural studies, biochemical assays, mouse models and cell lines to understand the mechanisms governing mammalian telomere end protection, length maintenance and replication.